Genomic Analysis of Perianal Fistulizing Crohn's Disease across Ancestries

Project Summary
Perianal fistulizing Crohn’s disease is a debilitating phenotype of Crohn’s disease (CD) involving the rectum. It
is often refractory to treatment and is associated with severe disability and poor quality of life. Fistulizing CD
disproportionately affects African Americans (AA), presenting with much higher prevalence, and more severe
with destructive pathology. Besides fistulizing CD often requires a more aggressive combination of medical and
surgical intervention than does luminal disease. Several lines of evidence suggest that interactions between the
rectal epithelium, the microbiome, and the immune system, drive patent-specific pathogenesis of perianal fistula,
but there is very little known about these at the molecular and cellular level, particularly with ancestral differences.
The complexity of perianal fistula involving communication between microbes and multiple immune and non-
immune cell types provides a strong rationale for a need for deep molecular characterization of the disease. One
hypothesis is that different biological mechanisms due in part to divergent genomic architecture between African-
and European-ancestry patients contributes to the disparity in health outcomes. Consequently, integrative
genomic comparisons utilizing state-of-the-art single cell gene expression profiling of rectal biopsies and of
peripheral blood immune cells, will be used to investigate the nature of pathological mechanisms of perianal
fistulizing CD including specific comparison of African and European ancestry patient groups. Building on
preliminary transcriptome profiling of the whole mucosa between these ancestry groups that implicates
differences in metabolic and inflammatory signaling, and taking advantage of the emerging Gut Cell Atlas, our
profiling of 120 cases will establish which cellular and gene expression features associate with remission,
stabilization, or progression of disease. Aim 1 is to biopsy rectum and take blood samples from 120 patients at
presentation, and again at follow-up, also with microbiome sampling (rectal wash as well as stool), supported by
deep clinical phenotyping. Two ancestral populations (European and AA) are equally powered for comparison
studies. Aim 2 is to use single cell RNA sequencing to profile changes in the relative abundance of each of
dozens of key cell types, and to identify key genes that are consistent biomarkers of the three therapeutic
response states within each cell type. Advanced bioinformatics approaches will be used to characterize the
network of cellular interactions, and to link the genetic regulation of gene expression to genome-wide association
studies of CD by identifying cell-type specific eQTL. Subsequently, in Aim 3, mechanistic dissection of specific
pathways will be pursued with in vitro cultures of patient-derived intestinal organoids to assess patient specific
responses when stimulated by relevant molecules. The findings will both illuminate cellular and molecular
mechanisms that contribute to a major source of health disparity in fistulizing CD, and support the transition to
personalized genomic medical profiling in support of therapeutic intervention.

Public health relevance
Narrative: Perianal fistulizing disease is a severe phenotype of Crohn’s disease (CD) which disproportionately affects African Americans (AA) making this a major cause of health disparity. We show that the ileal transcriptomic (mucosa) profile in AA is distinct compared with European Americans (EA), suggesting that these differences are due in part to biological mechanisms being driven by their unique genomic architecture. We will use single cell transcriptomics to profile each cell type at enrollment and follow up in an equal number of AA and EA, which will be followed by mechanistic studies with patient-derived intestinal organoids. This state-of-the-art hypothesis driven mechanistic study is designed to establish biological differences that might influence disease severity and outcome in 2 ancestral populations.